Molecular Origins of Neurodegeneration through Force Detangling of Toxic RNA

Nucleotide repeat expansion mutations cause progressive and lethal neurodegenerative
diseases such as Huntington’s Disease (HD) and amyotrophic lateral schlerosis (ALS). The
molecular reasons for the pathological effects of these mutations remain elusive. Most research
has focused on the toxic effects of the mutant proteins. The expanded repeat RNA, however,
has more recently been shown to be toxic to neurons and to contribute to disease. In
Huntington’s Disease, RNA containing 40 or more CAG repeats is known to associate with
itself, condensing into gel-like assemblies or aggregates. Nevertheless, the stability and
dynamics of the RNA interactions inside these condensates and aggregates are little known. It
is also not known what features of the RNA, if any, correlate with disease propensity. This lack
of progress is in part owing to the difficulty of studying interactions that are repetitive,
heterogeneous, and changeable. This project will develop a new single molecule tool to study
the structures and mechanical properties of abnormal CAG sequences in huntingtin mRNA.
Sensitive optical traps will be used to manipulate and unfold single RNA molecules. Integrated
real-time confocal fluorescence imaging of fluorophore-tagged RNA with microfluidics control of
the reaction components will track the build-up or dissolution of the RNA and protein complexes.
The first aim will determine the structure and stability of normal and expanded RNA and
compare them with the localization, aggregation, and toxicity of huntingtin RNA and protein in
cells. The second aim is to develop a real-time single molecule confocal assay to study the
mechanism of aggregation. The third aim is to develop a method for pulling on natural huntingtin
RNA complexes or aggregates isolated from cells, to understand how these aberrant structures
contribute to pathogenesis. Although this single force-spectroscopy method for studying RNA
aggregation is untried, the results have the potential to provide new information on the
molecular pathology of nucleotide repeat diseases. In the future, our single molecule tools can
be applied to many different RNA repeats and used to test small molecule inhibitors. The long-
term goal of this research is to identify a physical signature of huntingtin mRNA interactions that
predict neurotoxicity and that can be targeted by new therapies.

Public health relevance
Neurodegenerative diseases such as Huntington’s Disease and spinocerebellar ataxias are caused by inherited mutations in which the affected gene contains many extra copies of the three bases CAG. This research will develop new tools capable of imaging single RNA molecules to study how these mutations alter the mRNA structure and cause it to aggregate with other RNAs, resulting in cell death. The goal is to understand how these abnormal RNA structures harm neurons and cause deterioration of the brain.